Mitochondrial respiration as a regulator of lymphatic cell fate and therapeutic lymphangiogenesis

Summary
Endothelial cell (EC) metabolism has emerged as an essential driver and regulator of blood and lymphatic
vessel development, as well as an alternative approach in anti-angiogenic therapy. It has been shown that
metabolism is not only vital to EC function, but also to controlling different steps of the (lymph)-angiogenic
process. Lymphatic vessels show remarkable plasticity and heterogeneity, reflecting their functional
specialization to control the tissue microenvironment. Our recent findings revealed that by sensing the lymphatic
endothelial cell (LEC) differentiation status and microenvironmental metabolic conditions, mitochondrial
complex III regulates LEC fate specification and maintenance during embryonic development. Similar to what
was shown for blood endothelial cells, most likely in different pathological conditions, mitochondrial respiration
is also required for the growth and expansion (lymphangiogenesis) of lymphatics. We argue that mitochondrial
respiration sensing and regulation of the metabolic status of LECs is a critical step during developmental and
disease-promoted lymphangiogenesis, and we will evaluate this proposal in mouse models of cardiac injury and
induced acute and chronic pancreatitis.

Public health relevance
Project Narrative Findings from the past few years have changed traditional views about the role of lymphatics in health and disease. Lymphatics are now considered to be active, tissue-specific players in major physiological and pathophysiological processes, including cardiovascular, neurological, and metabolic diseases. Improving our understanding of the metabolic landscape of LECs in normal and pathological vascular beds should help us better characterize the complex, step-by-step process leading to the formation of fully mature vascular networks, and offer novel approaches for treating vascular diseases. Accordingly, the stimulation or blockage of LEC metabolism could potentially be used to promote or inhibit vessel growth.